Sex chromosome contributions to alcohol drinking behaviors

Project Summary
Men and women have differing vulnerabilities to alcohol. For example, men develop Alcohol Use Disorder at
higher rates but research shows that women may escalate their drinking faster and be more motivated to
resume use following abstinence. Preclinical research in animals consistently demonstrates higher rates of
consumption in females and that gonadal sex, chromosomal sex, and alcohol exposure interact to influence
levels of alcohol intake. In regards to chromosomal sex and alcohol drinking behaviors, a subset of genes of
interest on the X chromosome are of potential interest because of their ability to escape transcriptional
repression in brain tissues. The central hypothesis driving the proposed studies is that X chromosome dosage
influences alcohol consumption through overexpression of these genes, but that these effects may depend on
gonadal status or alcohol exposure history. Our experiments will test this hypothesis through completion of
three primary aims. We will 1) demonstrate that alcohol consumption is reduced in mice with two (i.e., XX) vs.
one (i.e., XY or XO) copies of the X chromosome, 2) determine whether a history of alcohol exposure alters
expression of genes that escape X chromosome inactivation in the brain and whether these effects depend on
gonadal status, and 3) identify the candidate gene Gprasp1 as a regulator of alcohol drinking behaviors via its
actions on dopamine receptors. These aims will be achieved through the use of two-bottle choice alcohol
drinking tasks, surgical gonadectomy, quantification of gene expression with RT-PCR, site-specific gene
knockdown, and pharmacological antagonism. Collectively, completion of these aims will demonstrate a role
for the X chromosome in alcohol consumption and determine which X chromosome genes that escape
inactivation in the brain are regulated by alcohol exposure. Further, we will identify GPCR regulation through
Gprasp1 as a mediator of sex differences in alcohol drinking behaviors. These studies will be the first
mechanistic demonstration of how sex chromosome complement influences vulnerability to alcohol.
Additionally, the proposed work and future related studies have a high likelihood of revealing multiple targets
with potential therapeutic efficacy for problematic drinking behaviors in people of all sexes and genders.

Public health relevance
Project Narrative Sex differences in vulnerability to alcohol suggest that alcohol drinking behaviors are influenced by different mechanisms in males and females. This project will use mouse models of alcohol consumption to investigate the contribution of X chromosome genes to drinking behaviors. Interactions with gonadal sex and alcohol exposure will also be explored. Understanding the neural mechanisms that drive differences in alcohol consumption will inform future therapies and treatments for Alcohol Use Disorder.